VALIDITY OF VENOUS OCCLUSION PLETHYSMOGRAPHY MEASURING FOREARM BLOOD FLOW

The purpose of this study is to compare two different non-invasive methods of measuring forearm blood flow when blood vessels in the arm are constricted such as would occur when one stands up.